Project 3: Repurposing Ceritinib for Ovarian Cancer Therapy

ABSTRACT – PROJECT 3
The 5-year survival for advanced high-grade serous ovarian cancer (HGSOC) is <30%. The introduction of
poly(ADP-ribose) polymerase (PARP) inhibitors (PARPis) has increased progression-free survival in patients
and may increase overall survival in some patients; however, the emergence of PARPi-resistant disease is an
escalating clinical problem. Accordingly, there is a pressing need to identify novel therapies that enhance PARPi
activity in HGSOC. Here we show that ceritinib, a small molecule kinase inhibitor approved for the treatment of
ALK-positive non-small cell lung cancer, synergizes with PARPis. This synergy is not due to ceritinib-induced
disruption of homologous recombination (HR) or ALK inhibition. Instead, ceritinib synergizes with PARPis, at
least in part, by inhibiting mitochondrial respiration, which induces the production of reactive oxygen species
(ROS) and consequent induction of DNA damage that is repaired via the PARP-dependent base excision report
(BER) pathway. Consistent with this mechanism of action, we show that a ceritinib + PARPi combination is
synergistic in HR-proficient and -deficient ovarian cancer cell lines. Moreover, in HGSOC patient-derived
xenograft (PDX) models, ceritinib + olaparib (C+O) induces tumor regressions and extends mouse survival more
effectively than olaparib alone. These observations raise the possibility that C+O will extend progression-free
survival or prevent the emergence of PARPi resistance in HGSOC. Despite this progress, it remains unclear
i) whether C+O can be safely given to patients, ii) whether C+O has activity against HGSOC in patients, and
iii) how to identify the ovarian cancers that will be most responsive to C+O. To begin the process of repurposing
ceritinib for ovarian cancer, we propose to i) perform a phase Ib trial of C+O with an expansion cohort and
correlative studies in platinum-sensitive relapsed ovarian cancer; ii) identify genes and pathways, including DNA
repair pathways, that affect C+O cytotoxicity in order to provide additional insight into the action of this
combination and potentially identify biomarkers of response; and iii) use PDX models to assess potential
genotypic and phenotypic differences that correlate with antitumor responses to C+O. The overarching goals of
these studies are to better understand the mechanism(s) of action of the C+O combination and identify ovarian
cancers most likely to respond to this combination in a future phase II trial in HGSOC. These studies, which
utilize the Biospecimens, Biostatistics and Bioinformatics, and Animal Models Cores, are designed to facilitate
the repurposing of ceritinib in combination with PARPis as a new therapy to improve the outcomes of PARPi-
treated HGSOC.

Public health relevance
NARRATIVE – PROJECT 3 Poly(ADP-ribose) polymerase (PARP) inhibitors have recently been FDA approved as maintenance therapy to extend progression-free survival in ovarian cancer. Here we study the effect of combining PARP inhibitors with an FDA-approved drug (the ALK inhibitor ceritinib) that is not currently used to treat high-grade serous ovarian cancer (HGSOC). Based on a novel mechanism of action we have discovered and the synergistic activity of the ceritinib + PARP inhibitor combination, we propose additional preclinical studies to better understand the mechanism by which this combination kills ovarian cancer cells in tissue culture and in ovarian cancer patient- derived xenografts in vivo. In addition, we propose to perform a phase 1b clinical trial of ceritinib in combination with the PARP inhibitor olaparib with an expansion phase in HGSOC to assay toxicity, assess potential activity, and explore biomarkers of response identified in the mechanistic and PDX studies.